Commensal modulation of Peri-implant Microbiome Dysbiosis via Veillonella parvula

ProjSeucmtmary
Peri-imipsalparnetviatdlieessnttr,uicntfilvaem,mdiasteotarhsylaeetatdolsososfjawbaornoeudnedntal
implanidtmspairimnoernhatelsalth-qruealloaiflttieyIfdpteo.saepsubhleiaclcotnhcbeercnaubsoene
lospsrogreastasreaspriadtaendoensortesptohnedrapetuoctoincvaelnlptyeiroinoadlaonnttiablacter
theraMpuiletshi.upmlaesntudhiaevfseiremsltyabltihsiahmtepdlhayngtiaenntderibocogrernoesriaotne
impldaengtradpartoidousncutcashs,titamniicurmopawrhtiiaccrhlaeesss,ociwaitiehndflamimnation
larfgreacotfpieorni-imcpalsaeins.t,Teii.tt,iasn(iTuim)-mepdeirait-eidmWphliailnitetwsietldilosc.umented
thtaittamniicurmopaarlttpieecrrlie-siimmpmluasnnuetrveiplrliamnabcryieinldyucoixnigdasttirveteshse,
effectthstahtecsheangheasvoenthpeeri-immipclraonbhtiaovnmeoebteeandequaitnevleystigated.
TheproporseesdeaaricmthsoinvestihggeeanteemteicchaneimspmlsobyyeVdeil/onpea/lrvauala,
bridmgiicnrgoorignoarnbaiilsomftiolsmusr,vainvcdeross-poropataletchtoignreenspotnose
environomxeindtasattlirveOesuspr.relimsitnuaddrieyemsonsttrhaiatntecdrefarsteeiedtaniuimn leve
peri-ipmlpalqaaurnaeetssociwaitasehidgnirfeidcuacnittntihobeniodivoeftrhspeietryi-ibmipolfainltms
thiasctoupwlietdhoevergroofVw.ptahrvSutlrao.pnrgelimdiantpaaoritynoatnantioxciadtaanltase
enzyemnecodbeytdhkeatAgenaesbeiankgesyurvsiyvsatltehmeantabVl.epsarvulsau'rsvwihvialle
mospteri-icmopmlmaennbtsaacltaerrdeieaplebtyTeidtanium-omxeiddiabatutirevIsdemtp.ortantly,
Veil/ondee/lmaonstwriadteesspmruetaudawliitoshrmpaalthogseuncashsP,.gingiavnaFdli.nsucleatum
anidtcsatalparsoettehcletastftreoormxidadtaimvaesgueggesactoimnmgunitrye-gluelvraeotlloIernt.yhis
projweecwtid,lelter(miti)hneeexamcetchanuissembdsyV.parvutlosaurvoixviedasttirve(esitsih,)reole
ofkatAanodthkeerayntioxeindzaynmitenmsodulabtiionfogixlimdattoilveeraann(dcieti,hiae)biolfoirtayl
pathotgoelnesverVaegil/eonek/altAtaoc'osloannisdzuerviintvheoermaulcossoatftisbsaurerdiuerriTnig­
mediaitnefdlammTahtleioonng.-gtoeaorlftmhwiosrikstoidentthldefyriveorfmsicrobidoymsebiionsis
peri-impalnatdnodteivteielsffiocpacainotuismisctrroabtifeaogtlrihmeasnagemoefpnetri-implant
diseaTsheoesb.jecotftihvpeeropowsoeridktsoassetshsheypothtehsaiutrvsimveaclhanoifsms
commenVseail/lonsep/lpaw.h,iecnhabtlheeoivrergroiwntthhniiscahreleeverbaygoerpdaalthotgoens
colopneirzie-immipclraocnbotimamlunaintldieeastdoclinidciasleaTshpero.posoebdjecwtilbileve
complientwemodaiAnim1s)t:oidenhtoiwtfyitanium-imnefldaimamtaetdionV.pparrvoumloates
overgroawnt2dh)t,odetertmhieenxetteonwthiVc.hparvuallatpeorlsymicirnofbeicaotluiroisnnveivo.
Thesfeindwiinplgrlsoviimdpeoritnasnitignthhtresoolfeorcaolmmenbsaacltienmroidaulamtiicnrgobiom
dysbiaonswdiiislnltrondouvcteehlerapteaurtgoiefpctesri-imtprleaanttmietnitss.

Public health relevance
Project Narrative Current antibacterial treatment strategies for peri-implantitis lack efficacy in resolving the destructive inflammation that causes loss of jawbone, which necessitates the comprehensive study of microbial biofilm pathogenicity around implants. This study aims to understand the role of 1/. parvula in the polymicrobial shift that takes place in the pathogenesis of Titaniummediated peri-implantitis by focusing upon its ability to crossprotect pathogenic bacteria from oxidative environmental stress.